Stiffness measurements in human lung slices to evaluate therapeutic and preventive potentials of anti-fibrotic drugs

Abstract
Idiopathic Pulmonary Fibrosis (IPF) is a rapidly progressing lung disease with no known cure. This therapeutic
gap partly reflects the failure of current drug discovery technologies. A common weakness is that they do not
provide a holistic assessment of a drug, largely due to the lack of direct evaluation of physiological endpoints
relevant to patient wellbeing. Thus, drug candidates can potentially be missed, or hits might ultimately have little
impact on patient wellbeing. We propose that parenchymal stiffness, a physical characteristic of tissue, is a
suitable target. The reason is that lung stiffness governs ventilation at the macroscale and can drive cellular
behaviors that promote and amplify IPF at the microscale. To measure macro- and micro-scale stiffness, we
have recently invented a biomechanical method suitable for implementation in human precision cut lung slices
(hPCLS). Using this method, our preliminary results show that the median and variance of IPF hPCLS stiffness
was ~3 and 30-fold greater than healthy hPCLS, respectively. Empowered by this data, our central hypothesis
is that the hPCLS stiffness map is well suited to evaluate whether a drug can therapeutically reduce, preemptively
slow, and/or stop IPF progression. To test this hypothesis, we seek to: 1) integrate micro- with macro-scale
stiffness measurements with traditional IPF discovery endpoints, and 2) demonstrate proof-of-concept in testing
the therapeutic and preventive capabilities of IPF drugs. Aim 1: To establish that hPCLS stiffness can be used
to evaluate the therapeutic capability of IPF drugs. We will achieve this by (1) improving stiffness maps to
associate local stiffness with specific alveolar structures, and (2) correlating alveolar stiffening with microscale
remodeling of alveolar architecture, collagen microstructure, and alpha smooth muscle actin. The measurements
will be obtained before and 5 days after treating IPF-derived hPCLS with Nintedanib that reduces type III collagen
production or Epigallocatechin Gallate that inhibits both lysyl oxidase (LOX, collagen cross-linking enzyme) and
transforming growth factor β1 (TGF β1) kinase. Aim 2: To establish that hPCLS stiffness can be used to evaluate
the preventive capability of IPF drugs. A key advantage of our approach is the ability to perform longitudinal and
noninvasive assessment of hPCLS stiffness. We will take advantage of this unique capability to monitor
spatiotemporal evolution of macro- and micro-scale stiffness together with fibrillar collagen deposition of each
hPCLS over 7 days, in the presence or absence of a well-established pro-fibrotic cocktail. The experiments will
be repeated after co-treating normal hPCLS samples with either Nintedanib or Epigallocatechin Gallate. Impacts:
In this phase I application, we will develop a stiffness-based IPF drug discovery platform. In a Phase II follow-
up, we will: 1) integrate the MechanoWell® with state-of-the-art multiomic approaches to better understand and
fine tune promising drug candidates, and 2) stride toward commercialization via beta testing at potential industry
and academic partner sites.

Public health relevance
Narrative Idiopathic pulmonary fibrosis is a rapidly progressing lung disease with no known cure. To enhance drug development approaches toward this need, we propose a human lung slice-based drug discovery assay that is focused directly on the physiological endpoint relevant to patient wellbeing, tissue stiffness. Our central hypothesis is that lung tissue stiffness is well-suited to evaluate both the therapeutic and preventative potential of candidate drugs.